Cortical and Brainstem Contributions to Binocular Eye Movements

The proposal challenges Hering’s theories of unitary conjugate and vergence commands that guide research
on the neural architecture of oculomotor systems and buttress strabismus intervention. In most oculomotor
research one eye is recorded, assuming that both eyes are “yoked”, rotating together. Yet most eye
movements acquire objects divorced from frontoparallel or midline trajectories, and their control is poorly
understood. While some evidence suggests the eyes are controlled independently, the assumptions of yoked
control nevertheless dominate oculomotor research. Consequently, neural oculomotor structures are
characterized as issuing cyclopean eye rotation commands. Recent monocular pursuit data from our lab argue
against yoked control of vergence movements, which continues to form the basis of almost all oculomotor
control models. We propose a new alternative model architecture with two synergistic components. One is
cognitive and cortical and it moves each eye slowly and separately. The other is reflexive and in the brainstem,
and it moves the eyes rapidly and conjugately as a pair. Our project has the potential to initiate revision of
strabismus assessment by questioning the validity of the critical AC/A ratio diagnostic, and potentially guide
clinicians’ decisions regarding intervention. Aims assess:
Aim 1. Does monocular viewing reveal hidden architecture of binocular eye movement coordination?
Our preliminary data show that during midline pursuit an occluded eye rotates inappropriately for the target’s
motion, often with conjugacy. This might be because the target is misperceived as displaced off the midline, or
eye rotation drifts in a random direction due to misperception of target depth. Alternatively, retinal motion in the
viewing eye triggers brainstem conjugate circuitry that adds conjugacy to the covered eye’s behavior as our
model postulates. We test if conjugacy arises because of misperceptions or of conjugate circuitry activation.
Aim 2. Do asymmetric eye movements reveal contributions of conjugate and independent systems? In
our model, the output of the rapid conjugate system is combined with that of a system that rotates each eye
slowly and independently. We will test predictions of the model concerning how inappropriate ocular intrusions
with Müller alignment and curiously slow midline saccades occur, as well as how asymmetric eye movements
acquire targets in 3D space.
Aim 3. Is the independent system influenced by cognition while the conjugate system is not?
In our data, monocular viewing of an object moving in depth often succeeds in driving vergence pursuit in the
covered eye but fails completely to drive vergence saccades. Furthermore, in the dark, smooth vergence
follows self-generated limb motion, but inappropriate, apparently reflexive conjugate saccades occur when
looking between thumbs “aligned” at different depths. We will test if only the slow system or rapid one is
influenced by cognition, and if they use endogenous signals to track targets.

Public health relevance
Results of the proposed experiments could refine strabismus diagnosis and intervention by suggesting that there is diagnostic value in characterizing separately each eye’s rotation dynamics. Furthermore, because the component mechanisms in our framework likely have different neural loci, their malfunction should manifest as distinct symptoms. Moreover, those different neural loci could vary in plasticity potential, and hence could respond differently to therapy, knowledge of which could improve intervention strategies for ocular misalignment disorders.